Transcriptional variation in human milk

PROJECT SUMMARY
The Centers for Disease Control recommends breastfeeding for the first six months of an infant’s life due to
significant long term health benefits for the infant and breastfeeding parent. Beyond meeting the nutritional needs
of the infant, human milk is a dynamic fluid with composition that changes to meet the needs of the infant as it
develops and bioactive components which provide protective immunity to the infant. However, much is still
unknown about the cells in the mammary gland which produce these prized components of human milk.
Currently, there are no FDA approved interventions known to boost milk production, so the 60-70% of parents
who struggle to lactate are left with little support to improve lactation outcomes and set infants up for the long-
term health benefits of breastfeeding. Recent studies using single cell RNA-sequencing (scRNA-seq) of the
mammary gland cells exfoliated into human milk have begun to characterize the cells that produce this dynamic
substance with the ultimate goal of improving understanding of the factors impacting milk production at a cellular
level. Still, the transcriptional pathways involved in milk production as well as the way these pathways change
as a result of maternal and infant factors remains poorly understood. This proposal will utilize existing data
generated from human milk to improve the understanding of transcriptional basis of milk production by (1) using
integrative analysis of existing scRNA-seq data to identify shared transcriptional pathways of lactation, (2)
developing statistical models to expose genes and pathways that change in milk in concordance with maternal
and infant characteristics, COVID-19 infection and vaccination, antibody concentrations, and human milk
oligosaccharide concentration, and (3) apply these and other models to understand the changes in the mammary
gland and milk composition as a result of COVID-19 infection and vaccination. This improved characterization of
milk production will lead to future studies on interventions to improve lactation outcomes and immune protection
from human milk. Research will take place at the Gladstone Institute of Data Science and Biotechnology, a highly
collaborative research institution with a commitment to postdoctoral training. The trainee with receive training in
statistical analysis and method development, lactation biology, immunology, and responsible conduct of research
from an interdisciplinary and multi-institutional team of mentors and collaborators. The training plan will prepare
the trainee for an independent career as a computational biologist studying lactation and maternal and infant
health.

Public health relevance
PROJECT NARRATIVE Human milk provides significant health benefits to infants as well as the lactating parent, and while breastfeeding is recommended for the first six months of life, many families struggle to initiate and maintain lactation. Few clinical interventions exist to improve lactation outcomes, in part due to lack of understanding of the cellular process of lactation by cells in the mammary gland. This study will leverage existing transcriptomic data of mammary gland cells from human milk to identify the gene pathways underlying the process of lactation and its response to disease.